Virulence Factors of Salmonella

PROJECT SUMMARY
Typhoid and paratyphoid fever are indistinguishable in their symptoms,
suggesting that typhoidal Salmonella serovars possess similar virulence strategies.
However, the identity of shared virulence strategies that set typhoidal Salmonella
serovars apart from non-typhoidal Salmonella serovars, such as S. enterica serovar
Typhimurium, remain understudied. Experiments proposed in this application are aimed
at addressing this important gap in knowledge. Our long-range goal is to elucidate the
molecular mechanisms by which typhoidal Salmonella serotypes manipulate host
responses during infection. The objectives of this application are to study the
contribution of genome decay in typhoidal Salmonella serovars, which includes gene
deletion or disruption (pseudogene formation), to their interaction with the human host.
Our central hypothesis is that genome decay in typhoidal Salmonella serovars is a key
driver of immune evasion. To test our hypothesis, we will determine whether pseudogen
formation enables S. Paratyphi A to evade complement activation (specific aim 1),
determine how reduced epithelial invasion caused by genome decay moderates gut
inflammation (specific aim 2) and determine how pseudogene formation enhances
Peyer's patch colonization (specific aim 3). Our analysis of virulence mechanisms
shared among typhoidal Salmonella serovars will be useful, and necessary, to
understand how the interplay between pathogen and the innate immune system gives
rise to responses that distinguish typhoid/paratyphoid fever from gastroenteritis, thereby
ushering in a significant conceptual advance.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Typhoidal Salmonella serovars cause an estimated 27 million cases of typhoid/paratyphoid fever each year. Due to the absence of convenient animals models to study these pathogens, our understanding of typhoid/paratyphoid fever pathogenesis is still incomplete. In this application, we will elucidate how typhoidal Salmonella serovars evade our immune system, which will provide important new insights into the pathogenesis of typhoid and paratyphoid fever.